CELL BIOLOGY OF MAMMALIAN EYE LENS IN CULTURE

Freshly isolated rabbit lenses were incubated in different culture mediums. It was found that the alteration of molarity of the medium (hypotonic or hypertonic) significantly inhibits protein metabolism; similar results were also obtained when the pH of the medium was varied. Hypertonic culture medium can induce temporary superficial cortical fiber opacity. Alpha-crystallin has a half-life of more than three days.